Infrastructure Development and Maintenance for the Utah Manufactured Food Regulatory Program, UDAF

RFA-FD-23-027 Infrastructure Development and Maintenance for the Utah Manufactured Food
Regulatory Program
Utah Department of Agriculture and Food
PROJECT SUMMARY
This is a three-year research project, conducted by the Utah Manufactured Food Regulatory
Program at the Utah Department of Agriculture and Food. This project will allow the program to
enhance and strengthen its capacity and infrastructure to continue supporting development of
skills and abilities to perform full-scope preventive controls for human food inspections and take
on more work under the FDA inspection contract, including full-scope dietary supplement
inspections. Other areas that will be prioritized are: continued maintenance of the MFRPS to stay
in full conformance, continued hiring and training of new and experienced manufactured food
inspectors, making a smooth transition in program management, training six more PC inspectors,
hiring a new MFRPS Coordinator, moving into Phase III auditing, and completing the work on
the current FDA Contract for FY2023. The program will continue to meet all the grant
requirements and participate in work planning and mutual reliance. Another critical priority is
the IT upgrades needed to fully implement data exchange to help support and advance the goal of
a national integrated food safety system (IFSS).
1

Public health relevance
RFA-FD-23-027 Infrastructure Development and Maintenance for the Utah Manufactured Food Regulatory Program Utah Department of Agriculture and Food OVERALL PROJECT NARRATIVE The overarching goals of the Utah Manufactured Food Regulatory Program for this three-year project are to continue to build on the capacity and infrastructure improvements that have been achieved during the past five-year grant period, and continue to build capacity to perform full- scope preventive controls and full-scope dietary supplement inspections under contract. 1